Parsing Neurobiological Bases of Heterogeneity in ADHD

PROJECT SUMMARY/ABSTRACT
Attention-Deficit/Hyperactivity Disorder (ADHD) is a highly heterogeneous disorder, with multifactorial
etiological risk factors, diverse expressions of symptoms, comorbidities, and long-term trajectories. An
approach to parsing such heterogeneity is to move beyond symptom ratings toward clinically meaningful
phenotypic measures that have well-theorized relations with neurobiological systems. This approach serves as
the basis of the NIH Research Domain Criteria (RDoC) framework. In the proposed study, we will explore
attention in an attempt to understand heterogeneity within children with ADHD. Reaction time variability (RTV),
an index of attention, is the cognitive correlate that typically demonstrates the largest effect size when
comparing ADHD to non-ADHD children. However, while RTV is considered a robust correlate of ADHD, its
etiology is unclear and individuals with ADHD themselves vary considerably on indices of RTV. Thus, first
establishing the neurobiological basis for RTV and then exploring if it can be used to understand heterogeneity
in ADHD is critical. The Adolescent Brain Cognitive Development (ABCD) study provides an unparalleled
opportunity to examine disordered attention, as indicated by RTV, in a large sample of children recruited at
ages 9 to 10 and followed longitudinally. ABCD measures include attentional tasks, diagnostic interviews, and
extensive neuroimaging. At baseline, 1079 children in ABCD met diagnostic criteria for ADHD. We propose to
utilize machine learning to explore the neurobiological basis of RTV using the entire ABCD neuroimaging
sample (n=9,598). We will also explore heterogeneity within ADHD by identifying groups of individuals
diagnosed with ADHD who are characterized by unique RTV and neuroimaging profiles. To establish the
validity of these profiles, we will examine their association with functioning. Machine learning focuses on
learning statistical functions from multidimensional data sets to make generalizable predictions about
individuals; it allows for inferences at the level of the individual and is sensitive to subtly distributed differences.
Thus, it is an ideal approach for deriving subject-level biomarkers. The first aim is to determine which
neuroimaging data are associated with each reaction time variable derived from Gaussian, ex-Gaussian, and
drift diffusion models. The second aim is to explore corresponding developmental trends in RTV and
neuroimaging data. The third aim is to a) identify groups of ADHD subjects with similar attentional profiles
and, b) explore the neurobiological signature of these attentional profiles using the data we derived in aim 1.
The fourth aim is to examine the clinical correlates of empirically-determined attentional profiles. Conceivably,
identifying mechanistic biomarkers of disordered attention reflected by RTV could refine pharmacological,
cognitive, and behavioral interventions; this could lead to a higher probability of success for treatments directed
toward that particular mechanism for individuals within specific ADHD subgroups. This work could also be
relevant for disordered attention in other disorders characterized by high levels of RTV (e.g., Autism).

Public health relevance
PROJECT NARRATIVE Psychiatric disorders pose challenges to neurobiological analysis as they are complex, routinely co-occur, and are operationalized using behavioral symptoms. We propose to examine the neurobiological basis of reaction time variability in the Adolescent Brain Cognitive Development (ABCD) study in order to explore heterogeneity in Attention-Deficit/Hyperactivity Disorder (ADHD). This work may help us better understand how to identify and treat individuals with ADHD.